Administrative Core

Project Summary/Abstract: The main goal of the BAATAAR-UP ARTNet Admin Core is to ensure regular
communication between the leaders and teams involved in Project 1 led by Dr. Bivona and Dr. Blakely (Clinical
tumor-TME acquired resistance), Project 2 led by Dr. Roth and Dr. Bivona (PDX tumor-TME acquired
resistance), Project 3 led by Dr. Bandyopadhyay and Dr. Kuo (PDO tumor- TME acquired resistance), and the
Data Science Core, led by Dr. Wang and Dr. Bandyopadhyay. Additional goals include ensuring regular
communication with the NCI, and other ARTNet centers as well as with the basic, translational, and clinical
scientific stakeholders, and with lung cancer advocacy groups and the public at large. These goals will be
accomplished through three specific aims. The first aim will be to effectively manage and integrate scientific
projects and budgets. The Admin Core will create a Leadership Team consisting of the Project and Data
Science Core Leads, which will evaluate the progress and impact of research accomplished through regular
monthly team meetings as well as an annual retreat. The Admin Core will also oversee the submission of
scientific progress reports to the NCI in collaboration with the Leadership Team. The second aim of the Admin
Core will be to organize intra and trans-institutional activities to ensure regular communication between the
project teams with each other and with the Data Sciences Core. The Admin Core will ensure resource and
data sharing between each Project and with the Data Science Core. The Admin Core will also ensure regular
communication between the Leadership Team and the Scientific Advisory Board (SAB), as well as the broader
scientific and patients advocacy community. This will be accomplished by organizing an annual research
retreat in which project teams will present research progress and receive feedback and guidance from the
SAB. The SAB will include a range of experts with extensive knowledge of EGFR and KRAS biology and
acquired resistance to molecular targeted therapies as well as clinical and patient expertise. The Admin Core
will also ensure regular presentation of our findings by coordinating travel and presentations at scientific
conferences. Finally, the Admin Core will ensure engagement with patient advocacy groups and the general
lay community. In these events, our scientific team will communicate our research to a diverse lay audience,
as well as seek input and observations from the community for our work. The third aim of the Admin Core is
to organize interactions with the NCI and other national ARTNet Centers. The Admin Core will spearhead
coordination and communication directly with the ARTNet Coordinating and Data Management Center
(CDMC) and NCI scientific staff, as well as coordinate teleconferences with other ARTNet centers and/or the
NCI scientific staff to communicate updates on the progress of the Research Program and enhance the
strength of interpersonal interactions among all ARTNet stakeholders.